Investigating Sleep-Related Disparities in U.S. Childrens Learning Difficulties

Project Summary/Abstract
Sleep is crucial for healthy childhood development. Yet nearly a third of U.S. elementary school children aged
6-11 experience suboptimal sleep health. This has direct and causal implications for learning including poorer
academic achievement, challenging behavior, and executive function (EF) dysregulation. Work suggesting
sleep’s educational importance during adolescence has led to recent policy changes like delaying school start
times. Yet to date, there are three gaps in the literature which require further investigation. First, few studies
have been designed to be causally-informative regarding the extent to which sleep is related to long-term
learning difficulties including in longitudinal analyses of nationally representative cohorts of U.S. children. This
has left unanswered questions regarding how sleep dynamically interrelates with learning throughout
development. For instance, does suboptimal sleep health cause children to experience learning difficulties, or
does a latent, stable trait affect both sleep health and learning? Second, whether the link between suboptimal
sleep health and poorer achievement is mediated by behavior or EF is unclear. Suboptimal sleep health is
thought to interfere with children’s learning through increased daytime sleepiness, which increases challenging
behaviors and compromises EF skills necessary for successful learning. Yet to date, the direct and indirect
links between suboptimal sleep health and achievement, EF, and behavior have not been explored in a
mediational analysis. Third, vulnerable populations, including children with disabilities, children of color, and
those from economically disadvantaged homes, are more likely to both experience learning difficulties and to
experience suboptimal sleep health. Suboptimal sleep health may therefore be an under-recognized
mechanism for why vulnerable populations disproportionately experience learning difficulties, but to date this
has been not been directly investigated. Our project is among the first to assess these gaps through analysis of
two nationally representative, longitudinal datasets that include rich and detailed data on both sleep health and
learning: the Fragile Families and Child Wellbeing Study, and the Early Childhood Longitudinal Study-
Kindergarten cohort of 2010-2011. Our aims are: 1) To better understand in what ways learning difficulties are
influenced by suboptimal sleep health including through potential mediational or reciprocal relations; and 2) To
ascertain whether a greater likelihood for suboptimal sleep health helps explain why vulnerable populations are
more likely to experience learning difficulties. We will assess these aims through rigorous methods stratified by
race/ethnicity, socioeconomic status, and disability that will offer causally-informed evidence regarding whether
sleep and learning dynamically interrelate during middle childhood (random-intercept cross-lagged panel
modeling) and better estimation of the direct and indirect paths by which suboptimal sleep health influences
learning difficulties (structural equation modeling). Our project thus has significant implications for the
development of sleep-related interventions that promote school readiness and continued healthy development.

Public health relevance
Project Narrative This study will be one of the first to use nationally representative, longitudinal data on U.S. children to investigate how sleep and learning interrelate throughout childhood. Our aims are to better understand 1) in what ways sleep may directly affect and/or be affected by learning, including whether challenging behavior and executive function dysregulation mediate the relation between sleep and academic achievement, and 2) to ascertain whether a greater likelihood for suboptimal sleep health helps explain why vulnerable populations (including children of color, children experiencing socioeconomic disadvantage, and children with disabilities) are more likely to experience learning difficulties. Overall, our project will inform the development of sleep- related interventions that promote school readiness and continued healthy child development, as well as provide insight into whether interventions targeting sleep health are especially likely to benefit vulnerable populations in the U.S.